SENSITIVITY TO INTRAVENOUS ETHANOL: GENETIC DETERMINANTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This research study will investigate genetic and environmental components thought to influence one’s reactions to mild or moderate doses of alcohol. The research is looking at how various factors of personality, physiology, genetics, and mood are related to peoples responses to infused alcohol and their general alcohol use. The study also involves completion of questionnaires [measures of substance use, mental health, etc.], and the collection of DNA [genetic information] to look at whether these predict peoples response to alcohol.